Core 2: Data Analysis Core (Analysis Core)

Project Summary
The Data Analysis Core supports the scientific objectives of the four research projects of this Research
Program Project primarily through data management and statistical analysis services. In this role, and through
collaboration with Design and Optimization Core and other Program Project investigators, the Data Analysis
Core will manage all Program Project data and will apply and interpret a variety of statistical techniques for
analyzing research project data to support the development of an optimized healthcare system smoking
program (the Comprehensive Chronic Care Smoking Treatment Program: CCCSTOP). Services provided by
the Analysis Core include: 1) cleaning, preparing, documenting, and sharing research project data for
subsequent statistical analysis; 2) conducting statistical analyses to address primary and secondary aims
associated with the four research projects, including the modeling of key binary and continuous outcomes in
relation to the main and interaction effects of studied intervention components using approaches such as linear
and logistic regression models; 3) development and application of statistical techniques to synthesize results
across multiple outcomes, particularly in the screening stages of the Multiphase Optimization Strategy (MOST)
approach; 4) implementation of cost-effectiveness analyses that will permit evaluation of treatment outcomes in
relation to the cost of treatment; 5) conducting analyses of qualitative and quantitative data to assist
Implementation Project investigators in the evaluation of intervention Reach, Efficacy, Adoption,
Implementation, and Maintenance (RE-AIM model); and 6) coordinating and consulting with Project and Core
Leaders to develop analytic plans that ensure that analyses address clinically and substantively important
research goals and to assist in interpretation of obtained results. Members of the Data Analysis Core will meet
regularly with investigators to ensure the scientific integrity of the research plan implementation, to monitor and
discuss overall progress as well as specific project needs, and to make decisions related to prioritization and
allocation of resources provided by the Data Analysis Core.

Public health relevance
Project Narrative The Data Analysis Core will provide data management and statistical analyses across all of the projects. These activities will support the identification of smoking interventions that, together, are intended to form an integrated and highly effective chronic care smoking treatment program for use in health systems. Such a program is expected to produce meaningful reductions in smoking prevalence over time and across a healthcare population.